Integrating Chemistry and Evolution to Illuminate Biology and Enable Novel Therapeutics

Integrating Chemistry and Evolution to Illuminate Biology and Enable Novel Therapeutics
Project Summary
Our laboratory has led three research programs at the interface of chemistry and evolution. In the first
program, we developed DNA-templated synthesis as a novel approach to synthesize and discover bioactive
small molecules and polymers that combines biological evolution with organic chemistry. In the second program,
we developed prime editing and base editing, two genome editing technologies that collectively enable precise
installation of point mutations, insertions, and deletions at targeted sites in mammalian genomes without
requiring double-stranded DNA breaks or donor DNA templates. In the third program, we have applied these
technologies to rescue animal models of human genetic diseases. This MIRA renewal seeks to advance these
three research programs towards novel small-molecule and genome-editing therapeutics.
In the first program, we developed DNA-templated synthesis, generated libraries of DNA-templated small
molecules containing >250,000 unique macrocycles, and performed in vitro selections on these libraries to
discover novel kinase and protease inhibitors, including the first physiological inhibitor of insulin-degrading
enzyme (IDE). Recently, we discovered a new class of macrocyclic cyclophilin inhibitors that include CypD-
specific variants, and solved X-ray co-crystal structures of several inhibitors bound to CypD. We propose to
understand the interactions between these macrocycles and CypD, determine the cellular activity of these
compounds, and develop specific inhibitors of other cyclophilins. We will also screen a new DNA-templated
library of ~640,000 macrocycles against additional targets of therapeutic interest including DNA repair proteins,
tumor suppressors, E3 ubiquitin ligases, interleukin and interleukin receptors, deubiquitinases, and ATPases.
In the second program, we developed base editing and prime editing, the two methods that enable
precision genome editing in mammalian cells without requiring double-strand DNA breaks or donor DNA
templates. Base editing installs transition mutations (C•G→T•A, or A•T→G•C) using programmable DNA-binding
proteins fused to natural or laboratory-evolved nucleobase deaminase enzymes, while prime editing enables the
installation of all possible types of small substitutions, insertions, deletions, and combinations thereof through
the use of Cas9–reverse transcriptase fusions that copy edited DNA information from an engineered prime
editing guide RNA directly into targeted sites in mammalian genomes. We propose to advance prime editing by
revealing the cell-state and cell-type requirements for efficient prime editing, engineering improved prime editing
systems, and developing methods for prime editor delivery into animal models of human genetic disease.
In the third program, we have integrated base editing with in vivo delivery methods to directly correct the
mutations that cause genetic diseases, achieving phenotypic rescue in animal models of tyrosinemia75, genetic
deafnesses53,76, Niemann-Pick syndrome55, and progeria. We propose to apply base editing and prime editing to
validate novel in vivo approaches to permanently treat chronic pain and spinal muscular atrophy (SMA).

Public health relevance
Integrating Chemistry and Evolution to Illuminate Biology and Enable Novel Therapeutics Project Narrative Our laboratory has led three research programs at the interface of chemistry and evolution. We developed an approach to the synthesis and discovery of bioactive small molecules that combines powerful aspects of biological evolution with synthetic organic chemistry; we developed base editing and prime editing, two genome editing technologies that collectively enable introduction of all possible point mutations, insertions, and deletions at targeted DNA sequences in human cells without cutting the DNA double helix; and we have applied these technologies to treat animal models of human genetic diseases by directly correcting the mutations that cause the diseases. This MIRA renewal seeks to advance these three research programs towards novel therapeutics.